FAMILIAL FACTORS IN BARRETT'S ESOPHAGUS

DESCRIPTION (provided by applicant) Advances in basic sciences often translate into an increased understanding of disease processes. Similarly, advances in endoscopic engineering also produce new technology with novel applications in clinical gastroenterology. I believe that patient-oriented researchers in gastrointestinal diseases and gastrointestinal endoscopy must translate advances in basic sciences and engineering technology to improved methods for patient care. Using my previous experience in basic research and training in advanced endoscopy, I have initiated and successfully implemented investigations that address this goal. My research objectives have been furthered by the opportunity to mentor several advanced gastroenterology fellows in the performance of specialized endoscopic procedures and patient-oriented research projects. These trainees are now productive clinical investigators in the field of gastrointestinal endoscopy. Protected time provided by this award will permit me to develop a meaningful research program that focuses on applying new endoscopic techniques and advances in human genetics to the evaluation of Barrett's esophagus and esophageal adenocarcinoma. The award will also further my education in two areas in which it is slightly deficient, viz., biostatistics and human genetics. Educational courses in these subjects and collaborations with experts in these fields will strengthen the development of my research program. Lastly, the award will allow me to teach advanced endoscopy to new trainees and mentor them in the development of their own research projects within my program. Esophageal adenocarcinoma is associated with a very poor prognosis. More effective screening, surveillance, and treatment strategies are required. The aim of the current proposal is to identify familial factors involved in the development of Barrett's esophagus and esophageal adenocarcinoma. The ultimate goal of this research program is to help identify the heritable genetic mutation(s) that determine susceptibility to Barrett's esophagus in order to improve screening and surveillance strategies for this disease.